Emory Integrated Proteomics Core

EMORY INTEGRATED PROTEOMICS SHARED RESOURCE
PROJECT SUMMARY / ABSTRACT
The mission of the Emory Integrated Proteomics Shared Resources (Proteomics SR) is to provide protein
analytical services using cutting-edge mass spectrometry (MS) in support of Winship Cancer Institute. The main
technology platform of Proteomics SR is liquid chromatography coupled with tandem mass spectrometry (LC-
MS/MS) for highly sensitive identification and quantification of proteins and their post-translational modifications
(PTMs). Proteomics SR is a critical technological resource for Winship investigators and has supported a broad
range of cancer projects related to cancer cell biology, genetics, epigenetics, and novel therapeutics. The primary
aims of the of Proteomics SR are to provide: (1) access to state-of-the-art mass spectrometry for both discovery
and targeted proteomic applications, (2) provide consultation, expert training, and support for proteomics-related
research projects, and (3) provide infrastructure and resources that advance collaborative multidisciplinary
research and innovation among Winship investigators. Collectively, these aims will lead to an increase in the
quality of proteomics data available to Winship investigators through experimental design optimization and
proper interpretation. The mass spectrometry technologies provided are vital to Winship researchers and key
findings from these proteomic studies are fundamental to Winship's efforts to improve the prevention, detection,
and treatment of human cancers.